Magnetic resonance imaging methods to track Treg distribution and homing for clinical applications

PROJECT SUMMARY
Regulatory T cell (Treg) infusion, alongside solid organ transplantation, is an emerging strategy which focuses
on rebalancing the Treg ratio in the transplanted organ to prevent rejection or loss. However, developing effective
therapeutics using live cells necessitates means to determine their in vivo biodistribution, persistence, and
efficacy after administration. Clinicians do not know the fate of injected cells, thus, interpreting cases of non-
responding patients remains a barrier to wider use.
Magnetic resonance imaging (MRI) is the only technique that is radiation-free, clinically translatable, and
enables direct visualization of labeled cells in vivo. Due to the clinical translation potential, MRI applications and
contrast agent development continue to see remarkable growth, especially in the cell tracking sphere.
Through this diversity supplement, our goal is to design, synthesize and characterize a novel click functional
dextran coated superparamagnetic Fe3O4 nanoparticles for in-vivo T cell tracking by 1H MRI.. We will
develop a novel Fe3O4 nanoparticle platform containing T cell directing functionalities for enhanced cell uptake
and improved contrast in MR imaging. Synthesis and derivatization of dextran coated Fe3O4 nanoparticles with
CD4, CD8 or CD25 click chemistry functionality will provide a platform to be used for T cell labeling and tracking.
Decorated nanoparticles will be optimized and tested in cell culture assays including uptake and viability
measurements. T cell tracking and homing will be evaluated in vivo in a murine models. If successful, this
platform will allow for more precise and personalized treatment approaches, potentially increasing the overall
response rates to cell therapy. This will give clinicians adequate tools through imaging to improve patient
management and overall outcomes.
The logical extension of this Aim would be to test longitudinal tracking capability of the cells labeled with
this new in-house probe. The rationale for developing our own platform with the CD25 target is two-fold. First, it
would minimize dependance on a patented product from Miltenyi. Second, the goal is to develop a universal
platform that would enable clicking of any target moiety of interest, such as CD4, CD8 and beyond for a multitude
of disease models, which corresponds to Brock’s comprehensive PhD thesis plan. This protected training
and research time will also provide necessary experience and education critical for Brock’s PhD trajectory
and future career as an independent scientist in academia.

Public health relevance
PROJECT NARRATIVE We aim to develop novel, non-invasive, clinically relevant magnetic resonance imaging (MRI) technologies to visualize therapeutic cell distribution and homing following systemic administration. If successful, the proposed work will provide scientists and clinicians with powerful and clinically translatable imaging tools to assess cell homing, survival and therapeutic efficacy and the means to accelerate therapy development. If awarded, this diversity supplement will support a meritorious graduate student towards his PhD and career goals.